Muscle-mediated protection against MODS

? DESCRIPTION (provided by applicant): Critically ill patients with sepsis, trauma and other serious medical conditions often develop multiple organ dysfunction syndrome (MODS) with high mortality rate (30-80%). There is no specific therapy to prevent or cure MODS beyond treatment of the underlying illness. Emerging evidence suggests that oxidative stress- induced endothelial activation in vital organs is a key step in the pathology as it leads to exacerbated inflammatory cell infiltration and tissue damage. Unfortunately, general antioxidants with no target specificity have failed in clinical trials. On the contrary, exercise training induces profond adaptations in skeletal muscle and other organs and confers significant protection. We have obtained new evidence in mice supporting a protective role of extracellular superoxide dismutase (EcSOD) from skeletal muscle, which has a heparin- binding domain for targeting endothelial cells. Exercise trained mice and muscle-specific EcSOD transgenic mice are protected from endotoxemia, a condition leads to MODS. We hypothesize that enhanced EcSOD expression in skeletal muscle protects against MODS by reducing endothelium oxidative stress and activation in peripheral vasculature. We propose two specific aims to test this hypothesis: 1) To determine if muscle-derived EcSOD mediates protection against MODS; and 2) To define the mechanism by which muscle- derived EcSOD inhibits endothelial cell activation and inflammatory cell-endothelial cell interaction. These aims are hypothesis-driven and based on evidence from the literature and our preliminary findings. We will use state-of-the-art approaches in clinically relevant animal models to elucidate a novel non-contractile function of skeletal muscle-derived antioxidant against a serious disease condition.

Public health relevance
PUBLIC HEALTH RELEVANCE: Critically ill patients with infection, trauma and other serve disease conditions often lose vital organ function, a condition called multiple organ dysnfuntion syndrome (MODS), with very high mortality (30-80%), and no effective treatment is available. We have found in mice that a powerful antioxidant enzyme called extracellular superoxide dismutase (EcSOD) is elevated in skeletal muscle by exercise training and can protect vital organs in MODS due to its redistribution to the blood vessels of the vital organs. Here, we propose to ascertain this important function of muscle EcSOD and to probe for the underlying reasons. The findings will provide valuable information for the prevention and treatment of this catastrophic medical condition and potentially many other medical conditions.